An Accurate Machine Learning Framework for Childhood Acute Myeloid Leukemia Subtype Identification by Integrating Bulk and Single-Cell Multi-Omics Data Within and Beyond the CCDI Ecosystem

Abstract
As a fatal childhood hematopoietic malignancy characterized by clonal expansion of immature myeloid
precursors, acute myeloid leukemia (AML) usually leads to bone marrow failure and impaired hematopoiesis.
AML has multiple distinct subtypes characterized by morphological, molecular, and genetic alterations.
Identifying AML subtypes can facilitate downstream risk stratification and tailored treatment design. While various
conventional methods like morphological analysis, cytogenetic analysis, immunophenotyping, or molecular
profiling have been used for AML subtype identification, they are usually costly, time-consuming, labor-intensive,
and sometimes inaccurate. Recent progress has witnessed the application of next generation sequencing (NGS)
for identifying AML subtypes, but they are limited to bulk NGS data, or single omics data only. With tons of omics
data being generated within and beyond the Childhood Cancer Data Initiative (CCDI) ecosystem, we
hypothesize that integration of single-cell and bulk multi-omics data including genomics, transcriptomics, and
epigenetics data will significantly facilitate subtype-specific biomarker discovery and boost the accuracy of AML
subtype identification. Under our parent award (CA036727), in this supplemental project, we propose to
develop an integrated machine learning (ML) framework for accurate and cost-effective AML subtype
identification by combining bulk and single-cell multi-omics data within and beyond CCDI ecosystem.
To achieve this, we plan to undertake two specific aims. In Aim 1, we will establish a knowledge-transfer ML
model that leverages large-scale bulk and single-cell transcriptomics data for AML subtype identification. Besides
identifying well-annotated AML subtypes, we will also explore novel AML subtypes by detecting rare cell types
from large-scale single cell data, from which cluster-specific and rare-cell-type specific gene signatures can be
transferred to the bulk transcriptomics data for improving performance of AML subtype identification. In Aim 2,
we will develop a multi-kernel learning and a multi-modal deep learning framework to systematically and
automatically integrate deep information related with AML subtypes from single-cell and bulk multi-omics data
(including genomics, transcriptomics, epigenomics) to further boost AML subtype identification. Our model is
flexible to tackle cases when only partial or incomplete multi-omics data are available for new patients. We
believe successful completion of this study will have direct impacts on improving downstream childhood AML
risk stratification, facilitating diagnosis and prognosis, and optimizing treatment selection. We also expect that
our proposed framework in this study can be customized and extensible to identifying subtypes of other pediatric,
adolescent, and young adult (AYA) cancers especially ultra-rare tumors.

Public health relevance
Project Narrative In this NCI Childhood Cancer Data Initiative (CCDI) supplement project, we propose to develop an accurate and cost-effective machine learning (ML) framework for childhood acute myeloid leukemia subtype identification by integrating various types of multi-omics data. If successful, our study will directly improve downstream childhood AML diagnosis, prognosis, and treatment. Our proposed framework in this study can also be extensible to identifying subtypes of other pediatric, adolescent, and young adult (AYA) cancers especially ultra-rare tumors.